Active surveillance and patient reported outcomes in a diverse population of prostate cancer patients

PROJECT SUMMARY/ABSTRACT
An increasing proportion of prostate cancers of low grade and low potential for progression are diagnosed
each year. Most men with these tumors are expected to have comparable survival as other men their age
without prostate cancer. Thus, active surveillance, or closely monitoring the course of disease with the
expectation to intervene with curative intent given evidence of cancer progression, is universally recommended
as a viable management option for men with tumors categorized as “very low risk” or “low risk”, particularly
given significant morbidities including urinary and bowel incontinence and sexual dysfunction associated with
surgery and radiation. Research suggests that men may not be adequately informed about their treatment
options and, even more concerning, there is evidence that discussion of the option of active surveillance is
done less often for minority men and men of low socioeconomic status. Furthermore, there has been virtually
no research on patient-reported outcomes (e.g., physical, mental, psychosocial well-being) and health related
quality of life among different racial/ethnic and socioeconomic groups. Conducted within a population-based
setting comprising a diverse mix of races/ethnicities and socioeconomic level, the proposed specific aims are
to: 1) Examine provider perspectives on patient racial/ethnic perceptions and preferences regarding active
surveillance; 2) Examine the prevalence of and determinants of active surveillance among very low and low
risk prostate cancer patients by race/ethnicity and socioeconomic status; and 3) Compare changes in patient-
reported outcomes by treatment, race/ethnicity, and socioeconomic status, and the contributions of
sociodemographic, clinical, and contextual (family, social networks, institutional/provider, neighborhood) factors
on patient-reported outcome changes. These aims will be addressed using a mixed methods study integrating
qualitative provider and patient interviews, a survey of providers, and a longitudinal patient survey with
interviews at baseline (2-3 months after diagnosis) and 12 and 24 months after baseline. All minority patients
and a 20% random sample of non-Hispanic Whites will be identified using an early-case ascertainment
process from the Greater Bay Area Cancer Registry and the local Veteran's Affairs health system. Multilevel
determinants of treatment decision-making process and patient-reported outcomes will include patients'
sociodemographic, cultural, psychosocial, and contextual factors. This population-based study, conducted
within a diverse population inclusive of a range of medical care settings, will enable us to understand the
contributing factors at multiple levels that drive the gaps in receipt of active surveillance. This information is
needed to determine who and how best to target interventions to ensure that all men are adequately informed
about their treatment options and provided the opportunity to engage in informed decisions regarding their
treatments.

Public health relevance
PROJECT NARRATIVE Active surveillance is an accepted management option for all men with very low risk and most men with low risk prostate cancer, particularly as definitive treatments including radiotherapy and radical prostatectomy are associated with significant treatment-associated morbidities including bowel, urinary, and sexual dysfunction; however, on average less than 40% of eligible men receive active surveillance. In identifying vulnerable sub- populations, results from this study will directly translate into clinic-level policies and practices directed towards improving patient counseling, providing culturally-relevant care, and ultimately ensuring that all men, regardless of race/ethnicity or socioeconomic status, have the opportunity to be fully informed about their treatment options and experience optimal wellness as a survivor.